Research Infrastructure Core

Project Summary:
The long-term goal of the Research Infrastructure Core (RIC) is to support, strengthen and expand
biomedical and behavioral research projects at Florida A&M University (FAMU). Over the past three
decades, tremendous success was achieved by FAMU PIs through the active support of the research
infrastructure component of the RCMI Program. FAMU researchers relied on the services provided such
as using key instrumental analysis and research personnel to gather data that were used to write NIH
proposals, develop and sustain funded projects, publish in refereed and indexed scientific journals, as
well as train graduate students successfully. There is a critical need now to invigorate these support
strategies to continue strengthening biomedical and behavioral research activities on campus. The focus
of the FAMU RCMI U54 Research Infrastructure Core will be on promoting innovative technologies that
support the proposed RCMI research projects, pilot projects, and other FAMU biomedical and behavioral
research initiatives that address health disparities experienced by racial and ethnic minorities, the rural
and urban poor and other medically underserved populations. The RIC will 1) provide state-of-the-art
analytical facilities including Proteomics, Flow Cytometry and Imaging, High Throughput Screening
(HTS), NMR, Molecular Modeling Techniques, Cytokine, Microarray and Epigenetics Analysis and Data
Management; 2) enhance and develop research skills and capabilities in drug discovery and
biotechnology by providing new technologies, training of faculty and other researchers in the use of the
facilities of the core; and 3) promote and develop knowledge by providing workshops, seminars and
short courses in drug discovery and biotechnology research applications to enhance research
proficiency. Supporting the infrastructure core is significant because it promotes meaningful
collaborations, allows sharing of resources and provides developmental and training opportunities for
minority scientists. In addition, the proposed Research Infrastructure Core is relevant to the NIH/NIMHD
mission pertaining to the development of the research infrastructure and training of investigators to
become more successful in obtaining competitive extramural support in biomedical and behavioral
research.